Susceptibility of African Green Monkeys (Chlorocebus aethiops sabaeus) to Rickettsia felis, the agent of flea-borne spotted fever

Flea-borne spotted fever (FBSF) caused by Rickettsia felis, a Gram -ve intracellular
bacterium, is a recently described (1994) emerging disease of people that has now been
described worldwide. The cat flea is the confirmed biological vector and reservoir although ticks
and mosquitoes can harbor R. felis. Since clinical signs of FBSF are non-specific and infections
can be asymptomatic, there might be considerable underreporting of the disease. Nevertheless,
infections, as determined by PCR of blood, are particularly common in febrile patients in countries
in Africa and Asia. To date R. felis has not been isolated from the blood of a FBSF patient.
As a newly described disease there are many questions relating to FBSF, including the
possibility of other vectors, the pathogenesis and immune responses to infection, and even as to
whether R. felis might not be pathogenic and detected only as a symbiont of a human parasite or
protozoan. These questions will be resolved as further patient data slowly accumulates and
clinical trials may be carried out. However, an appropriate animal model would greatly facilitate
and accelerate the investigation of the unanswered questions surrounding FBSF. Unfortunately,
the only information on infections in animals, from cats, dogs, guinea pigs, mice, opossums, and
rats, indicate none are suitable models. The most likely animal model should be a non-human
primate (NHP) as they are more closely related, anatomically and physiologically, to humans. To
date the only data on R. felis in NHPs is that the organism can be found in their feces.
The aim of our study is to determine if African green monkeys (Chlorocebus aethiops
sabaeus) (AGMs) are susceptible to experimental infection (intravenous inoculation) with the LSU
strain of R. felis. After infection, AGMs will be monitored for clinical signs, rickettsemia by PCR
and culture, antibody responses, and body organ damage and dysfunction. Only the minimum
number of animals required to meet the aim of the study will be used, and these will be housed
in open-air, dedicated facilities that are insect-proof but closely mirror their natural environment
at the study site on the Caribbean island of St Kitts. AGMs that develop severe signs will be given
doxycycline, the antibiotic recommended for treatment in people, which will enable a detailed
examination of the drug’s efficacy. If AGMs develop very severe signs with a poor prognosis, they
will be humanely euthanized and necropsied to determine the pathogenesis of infections.
If the AGMs are found susceptible, the data from the study will help researchers to decide
if AGMs are suitable models of R. felis infections that can be used in future pathogenesis,
transmission, diagnosis, and/or treatment studies.

Public health relevance
We will determine if African green monkeys (AGMs) can be infected with Rickettsia felis, a bacterium transmitted by cat fleas and the cause of flea-borne spotted fever (FBSF) in people. This is a recently discovered disease, first described in 1994 and now known to occur around the world with infections particularly common in countries in Africa and Asia. If AGMs can be infected, they might be suitable animal models which can be used to answer the many outstanding questions about FBSF.